New Sample Multiplexing Technologies to Identify Chemical Probes and Illuminate Ubiquitin Biology

Summary
Defects in ubiquitin (Ub) pathways are often responsible for cancer and devastating neurodegenerative
diseases. Because of its central role in biological circuits and the potential for therapeutic intervention, the Ub
system is an intense research area. Yet, Ub biology is highly complex, supported by over 500 Ub ligases and
nearly 100 deubiquitinases. Currently, this complexity and our limited understanding of Ub biology players and
their interactions are severe hindrances for targeted intervention in many diseases. Considering all possible
ways to address this complexity, two important approaches have strong potential to fundamentally
revolutionize our ability to unravel each protein's unique cellular role in Ub biology: i) sample multiplexing in
mass spectrometry-based proteomics to improve throughput at proteome-wide depth, and ii) chemical
proteomics to discover selective pharmacological tools to perturb and illuminate function.
Through efforts within the previous grant cycle, the level of sample multiplexing was increased, allowing the
proteome-wide comparison of expression and modification levels for 16 samples. In addition, a real-time
database search doubled throughput while improving quantitative accuracy. In this proposal, we now turn our
attention towards discovering chemical probes to study the Ub system through new chemical proteomics
workflows where mass spectrometry is already a mainstay. In Aim 1, we will create two next-generation
workflows—one for targeted and one for discovery proteomics—supporting isobaric tagging studies with
16plex reagents. The focus will be on fully integrating control over the scan decision process using external
software and an API for protein quantification which will improve depth and quantitative precision. Given that
reaction centers in most Ub system enzymes are cysteines (e.g., E2s, E3s, deubiquitinases), in Aim 2, we will
modify the Aim 1 workflows to allow reactive cysteine profiling in chemical proteomics. Research under this
aim will be completed with an eye toward establishing comprehensive protein-small molecule interaction
landscapes for entire libraries of electrophilic compounds on a scale of thousands of molecules. Our goal in
this Aim is to discover novel probes to Ub ligases and deubiquitinases. In Aim 3, we will create workflows to
discover small molecules that induce Ub-mediated protein degradation. We will first modify both the discovery
and targeted platforms from Aim 1 to allow us to work with starting amounts from cells growing in 96-well
screening plates. Next, a plate-based cellular assay will be developed to measure the proteome-wide
consequences of acute treatment with pools of compounds in each well, pinpointing compounds that directly
engage the Ub-proteasome system to degrade their targets. The realization of these three aims will i) provide
innovative new workflows for isobaric tagging studies, ii) generate new chemical probes as tools to study the
diverse roles of Ub in cellular processes, and iii) create new precursors for therapeutic intervention.

Public health relevance
Project Narrative The Ubiquitin System is an intense research area with great promise for the improvement of human health. In addition to its critical role in normal physiology, malfunctions in ubiquitin biology have been implicated as a contributing factor in the causation of many illnesses as diverse as diabetes, cancer, and Alzheimer's disease. This proposal will develop new mass spectrometry-based technologies for sample multiplexing specifically tailored to chemical biology workflows to define small molecule-protein interactions which can be used as precursors for therapeutic interventions. 0